A Cluster Randomized Trial of a Breast Cancer Treatment Decision Aid for Women 70+ with Low-Risk Stage I Breast Cancers

Widespread use of mammography screening and population aging has led to many women >70 years being
diagnosed with Stage I, estrogen receptor-positive (ER+), HER2-, breast cancer. Historically, standard
treatment included mastectomy or breast-conserving surgery (BCS) with sentinel lymph node biopsy (SLNB),
with BCS followed by radiotherapy (RT); and endocrine therapy following locoregional therapy. However, trials
have found that omitting RT after BCS and/or omitting SLNB in women >70 with these breast cancers does not
affect their survival and may reduce treatment morbidity. Thus, guidelines include omission of RT after BCS
and of SLNB in women >70 with these breast cancers as appropriate. Despite this, around 55% of women >70
with these breast cancers receive RT post BCS and 60% receive SLNB. Possibly because few breast surgeons
are trained to engage older women in shared decision making (SDM) around treatment. SDM is a process
where clinicians and patients work together to make treatment decisions based on the best available data and
patients values and preferences. Also, no decision aids (DAs) were designed to inform women >70 about the
benefits/harms of their multiple treatment options and the interplay of their health, life expectancy, values and
preferences in these decisions. SDM supported by DAs may improve decision quality while reducing
overtreatment since well-informed patients often choose not to receive care associated with little benefit (low-
value). Thus, our interdisciplinary team developed and pilot tested a SDM training program for breast surgeons
and a promising treatment DA for women >70 newly diagnosed with Stage I, ER+, HER2-, breast cancer. We
propose SDM POSSIBLE (SDM for People Over Seventy with Stage I Breast cancer to Learn and Engage), a
multisite surgeon-level cluster randomized trial to test the effects of our intervention (surgeon SDM training
plus patient DA). We aim to randomize 22 breast surgeons per arm to test training surgeons in SDM and
sending their patients (560 per arm) the DA on patient treatments and outcomes (Aim 1). We hypothesize that
significantly fewer patients cared for by intervention arm surgeons will receive any low-value care defined as
mastectomy, SLNB, or RT after BCS within 6 months of their first surgical encounter (primary outcome,
assessed administratively via chart abstraction) and there will be no difference on breast cancer recurrence or
survival, and overall survival per arm over 3.5 years. In Aim 2 we aim to recruit 340 patients (or caregivers for
those with incapacity) included in Aim 1 to complete 1-week and 6-month surveys to learn our intervention’s
effects on participant-reported SDM quality, knowledge, decisional conflict, and quality of life and our interven-
tion’s cost-effectiveness at 6 months. In Aim 3, we will examine our intervention’s effect on surgeon SDM self-
efficacy. In Aim 4, we will conduct >22 qualitative interviews with participants at 1-year and at study’s end and
with clinical staff at study’s end to learn contextual factors influencing intervention implementation. Our novel
intervention will likely lead to women >70 receiving more person-centered care and thus to better outcomes.

Public health relevance
Many women >70 years are diagnosed with Stage I (<2 centimeters), estrogen receptor-positive (ER+), human epidermal growth factor receptor 2 negative (HER2-) breast cancers and historically treatment for these breast cancers included mastectomy or breast-conserving surgery (BCS) with axillary node surgery (dissection or sentinel lymph node biopsy [SLNB]), with BCS followed by radiotherapy (RT). More recent trials have found that omitting RT after BCS and/or omitting lymph node surgery in women >70 with these breast cancers does not affect their survival and may reduce treatment complications; despite this, many older women still receive SLNB or RT after BCS possibly because they are not adequately informed about their treatment choices and their surgeons are not trained in shared decision making. Therefore, we propose SDM POSSIBLE (SDM for People Over Seventy with Stage I Breast cancer to Learn and Engage), a multisite parallel group-randomized trial to test the effects of training surgeons in shared decision making and providing their female patients aged 70 and older newly diagnosed with Stage I, ER+, HER2- breast cancer a workbook decision aid on the benefits and harms of different breast cancer treatments; we anticipate that our intervention will lead to older women making higher quality treatment decisions, to fewer older women choosing to have mastectomies, RT after BCS, or to having SLNB, and thus to better outcomes.